Ethanol Alteration of the Neurogenic Niche

Abstract.
Alcohol use disorders (AUDs) remain one of the nation's major public health problems with nearly 14% of
U.S. population meeting diagnostic criteria. Alcoholics demonstrate cognitive impairments that are related to a
loss of brain mass or neurodegeneration in regions such as the hippocampus, an effect that may recover with
abstinence. The mechanism of this recovery is not clear, however recent discoveries from our laboratory show
that alcohol-induced regulation of hippocampal neural stem cells and adult neurogenesis parallel the changes in
brain mass and cognition during alcohol intoxication (decrease/deficit) versus abstinence (increase/recovery).
Across the last funding period, our lab has shown that prior alcohol dependence results in a striking increase in
adult neurogenesis in abstinence, an effect due to the recruitment of neural stem and progenitor cells into active
cycling that drives this reactive neurogenesis response. Although this response appears reparative initially,
based on ethanol rats showing behavioral recovery on a hippocampal-dependent learning task, stem cell
activation has long term consequences. Specifically, reactive neurogenesis via neural stem cell activation can
deplete or exhaust the neural stem cell pool, ultimately resulting in decreased neurogenesis and impairments in
hippocampal structure and function in the long-term. Furthermore, the mechanism of neural stem cell activation
in models of AUDs is not known, but converging evidence from stem cell activation and alcohol neuroplasticity
literatures coupled with our preliminary data support a role for mammalian target of rapamycin (mTOR) signaling.
Thus, our overarching hypothesis is that reactive neurogenesis is initially beneficial, resulting from the
recruitment of neural stem cells out of quiescence via an induction of mTOR signaling from alcohol dependence,
but neural stem cell activation may come at the expense of neural stem cell depletion and an eventual detrimental
impact on hippocampal structure and function. Using an interdisciplinary array of histological, biochemical,
electrophysiological and behavioral approaches, we propose to examine the role of, consequences of, and
mechanisms of reactive neurogenesis in a four-day binge model of an AUD through three specific aims: 1)
Determine the role of reactive neurogenesis in structure, function, and recovery in abstinence after alcohol
dependence, 2) Test the hypothesis that reactive neurogenesis after alcohol dependence activates neural stem
cells out of quiescence to ultimately deplete / exhaust the neural stem cell pool, and 3) Define the role of mTOR
signaling in neural stem cell activation and reactive neurogenesis after alcohol dependence. Our ultimate goal
is to elucidate the role of adult neurogenesis in promoting structural and functional recovery in abstinence so
that future studies can target this pathway pharmacologically or behaviorally as a novel therapeutic strategy in
the treatment of alcoholic brain damage.

Public health relevance
Nearly 14% of the U.S. population meets diagnostic criteria of an Alcohol Use Disorder, commonly termed alcoholism. Alcoholic brain damage may recover with abstinence, but the mechanism of this recovery is not clear. This proposal investigates a potential mechanism of cellular recovery through the brains endogenous neural stem cell population in the hopes of identifying novel pharmacotherapeutic targets that promote endogenous recovery mechanisms for the treatment of alcoholic brain damage.